COBRE Center for Molecular Epidemiology - Equipment Supplement

Abstract Per application guidelines, the abstract information is included in Research Strategy.

Public health relevance
Project Narrative: The use of large biospecimen archives from well characterized studies in combination with new “omics” technologies have greatly advanced epidemiological and public health research. Often the rate and cost limiting steps for such large complex studies are related to the preanalytical retrieval, processing and preparation of the biospecimens prior to analysis. This project seeks to leverage current Biorepository Core capabilities and take advantage of high throughput automated upgrades to address these limitations for current and future users.